Neurosteroid regulation of placental inflammation

ABSTRACT
Diverse pregnancy pathologies, including preeclampsia and spontaneous preterm labor, share a broad
phenotype of placental inflammation. Placental inflammation is also a known risk factor for impaired
neurodevelopmental outcomes. It is characterized by elevated ratios of pro- to anti-inflammatory signaling
molecules, as well as activation of inflammatory pathways that promote these responses, such as Toll-like
receptor (TLR) and nuclear factor k B (NFkB) pathway activation. While investigating the impact of altered
placental neurosteroid production on brain development, we found a correlation between placental
allopregnanolone (ALLO) levels and molecular indicators of placental inflammation, an association not previously
described. Our new preliminary data from mouse and human placenta support a negative correlation between
placental ALLO levels and inflammatory status. We will leverage human placental biospies from the NICHD’s
Nulliparous Pregnancy Outcomes Study: Monitoring Mothers-to-be (nuMoM2b) cohort to define placental
neurosteroid and cytokine levels across multiple pregnancy pathologies. We will pair this assessment with
mechanistic manipulations in human placental explant (HPE) cultures from healthy, term pregnancies. The
impact of endogenous and exogenous ALLO exposure on human placental inflammation and inflammatory
signaling in both sexes will be assessed using state-of-the-art neurosteroid and cytokine analysis to: investigate
the reciprocal interactions of endogenous placental ALLO with placental production of immune mediators (Aim
1) and determine whether treatment with exogenous ALLO or its analogs can prevent placental inflammatory
responses. Since placental inﬂammation is a component of multiple pregnancy complications that result in
preterm delivery and severe neonatal illness, as well as a significant contributor to short- and long-term
neurodevelopmental risk in children, such as autism, we need to better understand the regulatory mechanism
controlling the placental inflammatory milieu. The experiments proposed here will fill key knowledge gaps in
understanding human placental endocrine and inflammatory function, point to possible circulating neurosteroid
biomarkers for at-risk fetuses and potentially produce new therapies to reduce placental inflammation before it
causes either acute or long-term injury to the fetus.

Public health relevance
NARRATIVE/PUBLIC HEALTH RELEVANCE Placental inﬂammation is a signiﬁcant risk factor for acute harm, such as preterm delivery and severe illness in the newborn, as well as long-term harm, including neurodevelopmental impairments like autism. Decreased production of placental neuroactive steroids, including the progesterone derivative allopregnanolone, may increase inflammatory factors in the placenta across a wide range of infectious and non-infectious placental pathologies, such as chorioamnionitis and preeclampsia; understanding the mechanisms that link placental steroids to the production of inflammatory signaling molecules can provide new therapies to reduce placental inflammation before it causes either acute or long-term injury to the fetus.